Development of adjunctive therapies directed at S. aureus amidases

Project Summary/Abstract Resistance to antimicrobial chemotherapies is a major contributor to morbidity, mortality, and rising healthcare costs. The prevalence of drug-resistant pathogens against conventional antibiotics has been rising over the last several decades. Of great concern is methicillin-resistant Staphylococcus aureus (MRSA), which is rapidly diminishing the available treatment options for S. aureus infections. As drug resistances continue to emerge there is an urgent need to develop alternative therapeutic approaches such as the development of adjunctive therapies to potentiate the activity of existing antimicrobials. Recently we have discovered that amidase activity of cell wall modifying enzymes (named SsaA1 and SsaA2) mediates S. aureus biofilm resistance to the conventional antibiotic fusidic acid. That is, genetic inactivation of ssaA1 or ssaA2 results in sensitivity of biofilms to fusidic acid. This result suggests that small molecules capable of inhibiting SsaA amidase activity could be used as an adjunctive in conjunction with fusidic acid to effectively eliminate S. aureus biofilms. Mutants in ssaA1 also displayed reduced frequency of fusidic acid resistance emergence, suggesting that in addition to rendering biofilm bacteria sensitive to an antimicrobial, small molecule SsaA amidase inhibitors would also reduce the emergence of drug resistant bacteria. SsaA amidases are an ideal target for small molecule therapies because they are located on the outside of cells making them readily accessible and because humans lack peptidoglycan and the associated biosynthetic machinery (including SsaA amidase homologous). The primary goal of this R21 research is to identify chemical inhibitors of SsaA amidase activity and characterize these molecules for use as potential adjunctive theraputics. To achieve the goal, we propose the following aims: (1) Identify chemical compounds that eliminate SsaA amidase activity via high throughput screening and (2) Elucidate the ability of SsaA chemical inhibitors to sensitize Staphylococcus biofilms to antimicrobial treatment in in vitro and in vivo models of biofilm development. During the next phase of research (R33), we plan on translating our basic findings for clinical applications by investigating chemical optimization of lead compounds, characterizing antimicrobial activity against other gram-positive pathogens, and developing formulation/delivery systems to be tested with in vivo animal models. The PI's experience in S. aureus biology and the strength of the University of Michigan's Center for Chemical Genomics uniquely position us to conduct this research and make profound discoveries.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) Staphylococcus aureus biofilm infections are very common and significantly increase morbidity and mortality of those developing infections. One reason for this is that S. aureus biofilms are up to 1000 times more resistant to antimicrobials than the same bacteria living in the free swimming/planktonic state. This resistance depends upon biofilm growth; growing the organisms in the planktonic state restores sensitivity. We have found that S. aureus mutants unable to produce the amidase SsaA are sensitive to some conventional antibiotic in the biofilm state. The proposed work will identify small molecules capable of inhibiting SsaA amidase activity and elucidate the ability of SsaA amidase chemical inhibitors to sensitize S. aureus biofilms to antimicrobial treatment. The completion of the proposed aims will result in the characterization and validation of a novel adjunctive therapeutic target (SsaA) in drug resistant S. aureus. Considering that new approaches are needed to treat biofilm infections and drug resistant bacteria, this work is at the forefront to the funding missions of the NIH to better treat, understand, and prevent infectious disease. __SpecificAimsTextDelimiter__ Specific Aims The prevalence of drug-resistant pathogens against conventional antibiotics has been rising over the last several decades. Resistance to antimicrobial chemotherapies is a major contributor to morbidity, mortality, and rising healthcare costs. Of great concern is methicillin-resistant Staphylococcus aureus (MRSA), which is rapidly diminishing the available treatment options for S. aureus infections. Before the discovery of antibiotics the mortality rate for S. aureus blood infections was greater than 90%. As drug resistances continue to emerge there is an urgent need to develop alternative therapeutic approaches such as the development of adjunctive therapies to potentiate the activity of existing antimicrobials. Many life threatening S. aureus infections, such as osteomyelitis, endocarditis, and implanted medical device infections, involve the colonization of host tissue or implanted surfaces and formation of a biofilm. Elimination of S. aureus biofilms is nearly impossible with conventional antibiotic approaches as the biofilm growth mode renders most traditional antibiotics ineffective. Biofilms are surface associated communities of bacteria that display extraordinary resistance to conventional antibiotic therapy and many persistent bacterial infections are thought to be biofilm associated. Recent work in the Boles lab has uncovered cell wall modifying enzymes (named SsaA1 and SsaA2) whose cell wall modifying amidase activity mediates biofilm resistance to the conventional antibiotic fusidic acid. That is, genetic inactivation of ssaA1 or ssaA2 results in sensitivity of biofilms to fusidic acid. This result suggests that small molecules capable of inhibiting SsaA amidase activity could be used as an adjunct in conjunction with fusidic acid to effectively eliminate S. aureus biofilms. Mutants in ssaA1 also displayed reduced frequency of fusidic acid resistance emergence, suggesting that in addition to rendering biofilm bacteria sensitive to an antimicrobial, small molecule SsaA amidase inhibitors would also reduce the emergence of drug resistant bacteria. SsaA amidases are an ideal target for small molecule therapies because they are located on the outside of cells making them readily accessible and because humans lack peptidoglycan and the associated biosynthetic machinery (including SsaA amidase homologous). The central hypothesis of this proposal is that chemical inhibition of the SsaA amidase activity will sensitize S. aureus biofilms to standard fusidic acid antimicrobial treatment and reduce the emergence of fusidic acid resistance. To address this hypothesis the following aims are proposed; the R21 phase aims are: Aim 1:Create and validate a high throughput assay for assessing SsaA amidase activity. SsaA1 is an amidase whose enzymatic activity cleaves peptide bridges that crosslink the peptidoglycan cell wall of gram- positive bacteria. We have purified SsaA1, demonstrated enzyme activity, designed a FRET peptide substrate, and will develop a high throughput 386-well biochemical assay to follow SsaA1 activity for screening inhibitors. Aim 2: Identify small molecules that eliminate SsaA1 amidase activity. Using the resources available at the University of Michigan Center for Chemical Genomics, a ~150,000 member chemical compound library will be screened and vetted to identify compounds capable of inhibiting SsaA amidase activity. The R33 phase will develop and analyze candidate molecules identified in the R21 phase. R33 aims are: Aim 3: Improve the efficacy of first generation compounds identified in the R21 phase and test their toxicity. We will synthesize improved compounds by using structure-activity relationship (SAR) data to refine chemical composition. The efficacy and toxicity of these molecules will then be assessed. Aim 4: Elucidate the ability of SsaA chemical inhibitors to sensitize Staphylococcus biofilms to antimicrobial treatment. Chemical inhibitors identified and substantiated in the above aims (along with previously identified inhibitors) will be analyzed for the ability to reduce S. aureus biofilm mediated antibiotic resistance in both in vitro and in vivo biofilm models. The frequency of fusidic acid resistant isolates will also be determined in the presence and absence of amidase inhibitors. The completion of these aims will result in the identification and initial validation of potential adjunctive therapies directed at drug-resistant S. aureus. Considering the threat antimicrobial-resistant pathogens pose to human health, this work is at the forefront to the funding missions of the NIH to better treat, understand, and prevent infectious disease. This work will serve as the foundation for future microbiological and adjunctive therapeutic studies that seek to: (1) extend our findings beyond S. aureus, and (2) translate our results to develop novel therapeutic inventions against pathogens.